Regulation of lung inflammation by crosstalk between dendritic cells and sensory neurons

Project Summary
The lung is a major target of infections and allergies. Dendritic cells (DCs) in the lung function as sensors of
the immune system that detect and process pathogens and allergens to activate T cell-dependent adaptive
immunity. In addition, pathogens and allergens often stimulate airway sensory neurons either directly or
indirectly, leading to primary defense response such as coughing and sneezing. Recent studies highlighted
the role of neurons in immune responses, but the interaction between these two sensor modules, DCs and
sensory neurons, in inflammation in the lung is incompletely understood.
Infection with helminth parasites is a major health burden worldwide. Some helminth species such as
roundworms and hookworms in humans and Nippostrongylus brasiliensis (Nb), a commonly used model agent
to study hookworm infection in mice, traffic to the lung during their life cycle and cause potent type 2
inflammation. The larvae of these parasites stay in the lung only transiently before they get coughed up and
swallowed to migrate to the intestine, where they eventually mature and lay eggs. Thus, the cough-triggering
sensory neurons seem to play an important role in their life cycle, but their role in the regulation of inflammation
remains unclear.
We previously identified CD301b/Mgl2 as a marker for the migratory type 2 conventional DCs in peripheral
organs including the lung, and showed that CD301b+ DCs are required for the differentiation of Th2 cells. We
recently found that CD301b+ DCs are required for Nb-induced lung inflammation as well as for timely clearance
of the parasite. Interestingly, our data also suggest that CD301b+ DCs and sensory neurons suppress each
other to regulate lung inflammation during Nb infection.
Based on these data, we hypothesize that Nb parasites are sensed by CD301b+ DCs and sensory neurons,
which then mutually regulate each other to orchestrate type 2 inflammation in the lung. By using Nb infection
as a model, the long-term goal of this project is to understand how sensory neurons modulate type 2
inflammation in the lung. Since the lung is a major site not only for helminth infection but also for other type 2
inflammation disorders such as allergy, asthma and fibrosis, understanding the mechanism for the regulation of
type 2 inflammation is of clinical relevance.

Public health relevance
Project Narrative During infection, lung sensory neurons play an important role in primary host defense by triggering coughing, but how they modulate inflammation in the lung is incompletely understood. On the other hand, dendritic cells (DCs) play a crucial role in immunity by sensing pathogens and activating T cells. By using a mouse model of helminth infection, the goal of this project is to understand how DCs and sensory neurons cooperate in orchestrating type 2 inflammatory responses in the lung.